Cardiac lineage determination and nuclear architecture

This R35 application proposes a conceptual framework in which a body of work produced by the PI over the past
20 years is utilized as the foundation for launching innovative studies that seek to incorporate cutting edge
understanding of nuclear architecture (how chromatin is organized in three dimensions in the nucleus) to produce
a novel paradigm of lineage determination and cell fate identity. The goal is to better understand how broad
gene expression programs that characterize cell identity are regulated in order to inform regenerative
approaches to cardiovascular disease. Preliminary data suggest that regions of the genome that are localized
to the nuclear periphery (called “lamin associated domains” or LADs) are silenced by specific histone marks,
including H3K9me2, and that these regions are released from the periphery upon lineage determination in order
to allow for simultaneous activation of entire gene programs. Data suggests that the H3K9me2 mark
characteristic of LADs is “remembered” through mitosis providing a mechanism for epigenetic memory of lineage
identity. The proposed model suggests that epigenetic marks such as H3K9me2 that define LADs are
recognized by “LAD-tethers” that mediate spatial localization, and that these histone epitopes can be “shielded”
by phosphorylation of adjacent amino acid residues of the histone tails (including phosphorylation of H3S10 and
H3T11). We propose to test that during mitosis, aurora B kinase which phosphorylates H3S10, acts to un-tether
LADs by shielding the H3K9me2 epitope, allowing for the release of LADs, subsequent breakdown of the nuclear
membrane and DNA replication, followed by removal of S10 phosphorylation and re-establishment of LADs as
the daughter nuclear membranes form around the exposed histone mark. Thus, if the genome-wide pattern of
LADs in a given cell defines its identity by representing a “code” of silenced alternative lineage programs, then
cellular identity can be remembered through mitosis and efficiently re-established in daughter cells. Implications
for reprogramming, trans-differentiation, asymmetric cell division, and stability of lineage identity (and thus
cancer susceptibility) will be explored. Signal transduction cascades that regulate dramatic changes in cellular
metabolism and function (such as the switch between glucose and fatty acid metabolism characteristic of
developing and ailing cardiac myocytes and of cancer cells) may impact nuclear architecture and LAD dynamics
by converging on phosphorylation of histone residues including H3T11. This notion is supported by published
data indicating that a nuclear form of pyruvate kinase that is implicated in metabolic shifts can phosphorylate
H3T11 and can interact with Hdac3 which we have shown is a LAD tether, resulting in epigenetic changes and
activation of specific gene loci. Thus, this proposal provides the opportunity to provide experimental support for
a model of gene regulation and cellular identity that incorporates three dimensional regulation of chromatin
packaging within the nucleus extending our understanding of cellular identity and providing a novel mechanism
to understand the way in which entire gene programs are coordinately regulated.

Public health relevance
This application from an established and highly productive cardiovascular and stem cell scientist focuses on the ways in which cells regulate the genes that they express so that scientists will be better able to promote regenerative therapies for cardiac diseases such as heart attacks. Recent studies indicate that DNA is organized in highly complex ways within the nucleus and that gene expression is regulated, at least in part, by spatial localization within nuclear compartments. DNA tethered tightly to the inner nuclear membrane in regions known as lamin associated domains, is repressed, and this proposal will seek to explore the emerging concept that cellular identity can be manipulated by controlling the regions of DNA that associate with the nuclear membrane with the goal of enhancing cardiac regeneration.